A Nonhuman Primate Model of Early Alzheimer's Disease Pathogenesis

Project Summary The vast majority of Alzheimer's disease (AD) cases are late-onset and it ss now widely believed that development of late-onset AD is the consequence of accumulated brain damage over many years. This process begins with the generation of abnormal oligomeric proteins (amyloid beta oligomers, AβOs) from misprocessed amyloid precursor protein. AβOs are toxic to synapses, and over time AβO buildup and synaptic damage lead to deposition of amyloid plaques and hyperphosphorylated tau protein causing neurofibrillary tangles and neuronal loss, the hallmarks of AD neuropathology. Despite tremendous resource investment, the translation of this mechanistic understanding of AD pathogenesis into new therapies for AD remains elusive. We propose the development of a nonhuman primate model of early AD pathogenesis based on exogenous administration of AβOs to middle-aged rhesus monkeys. Our extensive preliminary data show that a month of twice-weekly AβO administration causes synapse loss targeted to highly plastic thin dendritic spines, and neuroinflammation, changes that mirror what is thought to occur in the earliest prodromal phase of human AD. This model therefore addresses a key limitation of existing animal models of AD: it is based on the pathogenetic process thought to lead to the vast majority of human late-onset AD cases. Based on the acute effects of AβO administration on synaptic and glial markers in rhesus monkeys, we hypothesize that deficits in cognition and affect mirroring symptoms of AD in humans will develop over time in rhesus monkeys chronically treated with AβOs and relate to synaptic disease observed in postmortem histology. To test our hypothesis, rhesus monkeys treated with AβOs or a scrambled peptide control will complete cognitive and affective tasks sensitive to cortical and subcortical function. Our design provides detailed assessment of the time course of behavioral changes, and we will determine synaptic, neuronal, and glial markers in the brains of these monkeys concurrently with the emergence of behavioral deficits. Behavior will be tested in repeated cycles so that changes over time with increasing cumulative dose of AβOs can be determined. These experiments will provide a multi-faceted behavioral characterization of how synaptic dysfunction caused by AβO treatment impacts cognitive and affective behaviors dependent on multiple cortical and subcortical structures, and will let us develop AβO administration in rhesus monkeys as a model for testing interventions that may derail the progression of pathological cascades before full-blown AD develops, providing a new setting for developing treatments for an urgent public health problem.

Public health relevance
Project Narrative Most preclinical research on therapies for Alzheimer's disease (AD) is based on genetic mouse models that are engineered with mutations found in humans with familial, early-onset AD, yet most cases of AD in humans are late-onset, unrelated to genetic mutations, and thought to be caused by a disease cascade initiated by formation of abnormal amyloid beta oligomer proteins (AβOs) produced by misprocessing of the amyloid precursor protein. In this project, we will model this process in rhesus monkeys by administering AβOs directly into their cerebroventricular system and test behavior over time as AβO administration continues, mapping the development of behavioral changes to synaptic, neuronal, and glial abnormalities caused by AβOs. This project will therefore generate a new model system in which to test therapies aimed at interrupting early pathological events in AD.